The AVANÇO Research Consortium: A Mozambique/Brazil/Texas Alliance to advance novel and affordable technologies for the prevention and diagnosis of cervical cancer in women living with HIV

ABSTRACT
The overall vision of the AVANÇO Research Consortium is to establish sustainable infrastructure
to develop research programs focused on HIV-associated malignancies in Brazil and
Mozambique. The research theme chosen for this U54 HIV-Associated Malignancy Research
Center (HAMRC) is to develop novel, low-cost and technologically feasible approaches for
cervical cancer screening, diagnosis, and treatment in women living with HIV (WLWH) in low- and
middle-income countries (LMICs). This HAMRC will be a collaboration between institutions in the
US, Mozambique and Brazil and includes investigators with expertise in HIV/AIDS, Cervical
Cancer, Bioengineering, Pathology, Epidemiology and Behavioral Science. The investigators
have several ongoing scientific and clinical collaborations which include projects across all three
countries.
Our proposal addresses the NIH priority: To address HIV-associated comorbidities, coinfections
and complications, which includes Malignancies as a category. HIV infection is a known risk factor
for cervical cancer, with WLWH having an approximate 6-fold increased risk of developing cervical
cancer.
The overall goals of the AVANÇO Research Consortium include:
1) Establish sustainable research infrastructure to perform multi-institutional research studies
related to HIV-associated malignancies across institutions in the US, Brazil and Mozambique. We
will build a comprehensive research program focused on identifying novel, low-cost and
technologically feasible approaches for the prevention, diagnosis, and treatment of cervical
cancer in WLWH in LMICs.
2) Conduct two Research Projects that advance the development of promising low-cost
technologies focused on the diagnoses of high-grade cervical dysplasia and invasive cervical
cancer among WLWH.
3) Facilitate and enhance the professional development of junior investigators to conduct HIV-
associated malignancy research in Mozambique and Brazil. Through our Developmental Core
and Shared Resource Core, we will build research capacity and collaboration through formal
research training courses, pilot project funding, and implementation of a Project ECHO® program
for research capacity building focused on mentoring and supporting early-career investigators.

Public health relevance
NARRATIVE Cervical cancer is the 4th most common cancer in women worldwide, with over 85% of cases and related deaths occurring in low- and middle-income countries (LMICs). Human immunodeficiency virus (HIV) infection is a known risk factor, with women living with HIV (WLWH) having a 5–8-fold increased risk of developing cervical cancer. The AVANÇO Research Consortium is a collaboration between Mozambique, Brazil and the US to advance novel and affordable technologies for the prevention and diagnosis of cervical cancer among WLWH in LMICs.